Flow cytometric analysis of benign and malignant tumors

The Flow Cytometry Unit provides comprehensive clinical flow cytometric evaluation of blood, bone marrow, fine needle aspirates, tissue biopsies, and body fluids for the diagnosis and monitoring of hematolymphoid neoplasia in NIH patients. The laboratory supports numerous NCI clinical protocols by offering diagnostic testing for leukemia and lymphoma, either as endpoint evaluations or for determining patient eligibility. A major focus of the Unit is the detection of minimal residual disease (MRD) with high sensitivity, down to levels 10^-5. In addition, the laboratory performs specialized assays to measure tumor cell characteristics required for protocol enrollment, many of which are not available through commercial or academic laboratories. Considerable effort is devoted to the development and validation of these unique, protocol-specific tests. The Flow Cytometry Unit also plays an active role in educating NIH staff and the broader medical community on the appropriate application of flow cytometry in clinical practice.